Resolving the paradoxical effects of subthalamic deep-brain stimulation on inhibitory motor control

ABSTRACT
Parkinson’s disease (PD) is the most common hypokinetic movement disorder. It is characterized by an over-
inhibited motor system, which results in bradykinesia, tremor, and stiffness of gait. Deep-brain stimulation (DBS)
is the primary neurosurgical treatment of PD. It commonly targets the subthalamic nucleus (STN) of the basal
ganglia, the primary inhibitory node in the motor system. One purported mechanism underlying STN DBS is that
it reduces STN’s inhibitory influence, thereby moving the pathologically inhibited motor system back to a more
typical excitation-inhibition balance. However, this is only one of the many competing explanations for the
mechanism underlying STN DBS’ therapeutic effect. To adjudicate between these explanations, there is a critical
need to precisely assess the inhibitory motor control function of the STN.
The premier method to assess inhibitory motor control is the stop-signal task (SST), in which inhibition is
needed to periodically stop an already-initiated action. Converging evidence shows that STN activity correlates
with the ability to successfully stop an action in the SST. As such, the SST is the ideal method to assess the
mechanism(s) underlying STN DBS, as it links STN activity with its purported function. The prediction is
straightforward: if DBS indeed reduces STN’s inhibitory influence, it should impair SST performance.
However, existing work has produced a highly contradictory, paradoxical picture of STN DBS’ effect
on motor inhibition: while some studies do show the predicted pattern, other studies show the exact opposite:
DBS seemingly improves action-stopping. The current proposal asks a very simple question: How can this be?
Previous work has not been able to answer that question, partially because small sample sizes prevented the
investigation of individual differences, and partially because methods to assess some key variables did not exist.
The core hypothesis of the current work is that DBS’s effects on motor inhibition are mediated by DBS lead
placement (Aim 1), cortico-STN connectivity (Aims 1 & 2), and/or task-related cortical dynamics (Aim 3).
We propose to investigate these aspects in a large sample of N=100 PD patients, who will perform two
sessions of the SST – On and Off DBS. In Aim 1, we will reconstruct the exact location of the implanted STN
leads, as well as the associated structural connectivity to the rest of the brain, and test whether changes in motor
inhibition are related to systematic variation in either. In Aim 2, we will investigate the same for cortico-STN
functional / effective connectivity, as assessed using EEG and a new method for concurrent task-related LFP
recordings. In Aim 3, we will focus on local cortical activity measured by EEG to test if secondary network-effects
of DBS contribute to different effects on motor inhibition. If successful, this work would provide unprecedented
insights into STN’s role in inhibitory motor control, resolve an unaddressed paradox in existing work, lay the
methodological groundwork for the comprehensive, causal study of cortico-subcortical circuits and human
behavior, and provide novel insights into the mechanism(s) underlying STN DBS.

Public health relevance
PROJECT NARRATIVE Deep-brain stimulation (DBS) of the subthalamic nucleus (STN) is used to neurosurgically treat Parkinson’s Disease and ostensibly works by reducing the inhibitory influence of the STN on the motor system, which alleviates the hypokinetic symptoms of the disorder. Surprisingly, however, STN DBS has highly paradoxical effects on the most common behavioral measurements of inhibitory motor control in humans, where it often improves the ability to inhibit movement. We propose to investigate the nature of this paradoxical variability through an unprecedently large sample of STN DBS patients, in which we will specifically investigate the hitherto- unexamined effects of STN lead location, cortico-STN connectivity, and DBS-induced changes to remote cortical dynamics on inhibitory motor control behavior.